Deciphering Clonal Hematopoiesis via Single-Cell Multi-omics

Project Summary
Almost all tissues acquire spontaneous somatic mutations that can result in subsequent clonal expansion. Such
clonal expansions are readily observable in peripheral blood samples as a patient’s age increases. This
phenomenon, referred to as clonal hematopoiesis (CH), increases an individual’s risk for hematologic
malignancies and cardiovascular disease, and has a prevalence over 10% in patients over the age of 65.
Amongst the more frequently mutated genes in CH, as well as in subsequent malignancies such as acute myeloid
leukemia (AML), are genes associated with DNA methylation, such as DNMT3A. However, the process through
which clonal hematopoiesis occurs and gives rise to these diseases is unknown. This project seeks to uncover
the biological impacts of these somatic mutations on hematopoiesis, which allow hematologic cells to transform
into malignancies and impact cardiovascular health. Specifically, this project aims to characterize the effects of
DNMT3A mutations on gene transcription, DNA methylation, and chromatin accessibility, to provide insight into
the progression from clonal hematopoiesis to disease.
The main approach in this proposal centers around single-cell sequencing along with genotyping of individual
cells. In Specific Aim 1, I will use our lab’s recently developed Genotyping of Transcriptomes method to compare
the transcriptional landscape of wild-type and mutant hematopoietic progenitor cells. This will provide insight into
differentiation fate skews as well as changes in gene expression associated with the somatic mutations. In
Specific Aim 2, I will use similar methods developed in our lab to combine single-cell methylome and chromatin
accessibility profiling with somatic genotyping in order to identify putative mechanisms that could explain the
changes in transcription and cell-fate determination. The outcomes of this study will inform the pathogenesis of
normal hematopoiesis to CH to malignancy, providing useful insights into the role of screening for CH as well as
possible therapeutic options to prevent the progression of disease. This project will be ideal for an aspiring
physician-scientist in training, given its blend of novel sequencing technologies applied to clinical samples
analyzed using cutting-edge computational biological methods, along with its possible implications for clinical
recommendations. With the mentorship of my sponsor, co-sponsor, thesis committee, leadership of the Tri-I MD-
PhD program, and the support of this fellowship, I am confident I will be well prepared to pursue and achieve my
goal of being a physician scientist and independent investigator.

Public health relevance
Project Narrative Clonal hematopoiesis, a condition where stem cells of the blood acquire mutations and experience increased rates of division, is a relatively common phenomenon, with an incidence of over 10% in patients over the age of 65. Importantly, while patients with clonal hematopoiesis do not experience any symptoms as a result of these mutations, they are at significantly increased risk for developing blood cancers and cardiovascular disease. Using genetic analysis that permits identification of these mutations in single cells, and therefore resolving the admixture of wild type and mutant cells within a sample, this project aims to uncover the processes by which clonal hematopoiesis develops into more serious disease.